Department of Veterans Affairs Rehabilitation Research & Development Center for Limb Loss and MoBility (CLiMB)

CENTER SUMMARY/ABSTRACT
The mission of the Center for Limb Loss and MoBility (CLiMB) is to preserve, restore, and enhance functional
mobility, independence, and participation in Veterans with lower limb loss or other musculoskeletal impairments.
CLiMB serves Veterans with mobility disabilities arising from medical comorbidities or post-service trauma, as
well as those with injuries sustained while on active duty, including small but important cohorts of women and
other under-represented minorities. CLiMB accomplishes this mission by conducting innovative and rigorous
research; disseminating discoveries to Veteran patients and providers, VA leadership, and other stakeholders;
and translating knowledge and devices into clinical care. CLiMB’s nationally and internationally recognized
Principal Investigators are a multidisciplinary group of clinician-scientists, engineers, biomechanists, and
epidemiologists. The Center’s scientific approaches and research Focus Areas span basic science, through
engineering design and development, to applied clinical research. CLiMB’s research Focus Areas are rooted in
the parallel importance of studying (1) Prevention of impairment onset and progression, (2) Innovative mobility
device development, (3) Evidence-based treatment and rehabilitation interventions, and (4) Personalized
surgical and prosthetic/orthotic treatment interventions. Focus Area projects are conceived through a synergistic
collaboration with patients, clinicians, clinician-scientists, and scientists both within and outside the Center who
identify and define unmet clinical needs in our Veteran patients. Project success is achieved through CLiMB’s
clinical translational pathway where projects often begin in a Discovery or Innovation phase and culminate in
clinical Translation. Consequently, the Center has placed a significant emphasis on ensuring that its research
and innovations have a demonstrated clinical need and a pathway to translation to ensure that Veterans benefit
directly from its work. CLiMB Translation can take on different forms (knowledge and devices) including evidence
to support clinical practice guidelines, physician decision support tools, patient decision aids available at the
point of care, and collaborations with industry to commercialize devices that are made available to Veterans.
CLiMB’s success and achievements are the result of unique laboratory and intellectual resources that cut across
our Focus Areas. These Core resources accelerate and facilitate the collaborative work of internationally
renowned clinicians and scientists with complementary expertise in rehabilitation science, engineering, and
clinical care. These resources have been cultivated by our Center for years, and with this renewal we are further
formalizing their structure, leadership, and purpose to include the following seven Cores: (1) Biomechanics &
Basic Science, (2) Imaging & Motion Analysis, (3) Computational Modeling, (4) Rapid Prototyping, (5) Clinical
Study Design, Epidemiology, & Biostatistics, (6) Novel Technologies & Applications, and (7) Administration &
Protection of Human Subjects. CLiMB’s future work will take a major step forward based upon the interim
evolution of engineering discoveries, unique to CLiMB resources, and the emergence of validated innovation
and decision support tools. In 2021, the Center has ten PIs who are committed to finding new ways of treating
Veterans with lower limb loss or other musculoskeletal impairments and translating these findings to the point of
Veteran care. Its planned innovative studies will harness novel technologies and applications including: the
unique aspects of 3D printing, musculoskeletal simulation, and prosthetic emulation to develop novel and
personalized approaches to prosthetic/orthotic prescription; state-of-the-art imaging and motion analysis
techniques to understand and treat orthopedic maladies; decision support tools for amputation-level shared
decision making to maximize functional outcomes; and cutting edge rehabilitation strategies to optimize healing
and reduce pain. CLiMB will accomplish this mission while continuing its commitment to the training of the next
generation of investigators.

Public health relevance
CENTER NARRATIVE CLiMB’s mission is to preserve, restore, and enhance functional mobility, independence, and participation in Veterans with lower limb loss or other musculoskeletal impairments. To accomplish this mission, CLiMB conducts research to prevent Veterans from developing disabilities from diseases, develops innovative devices to assist Veterans in their mobility, discovers effective treatment and rehabilitation strategies, and creates treatments and clinical tools that allow for an individualized approach to treating Veterans. The Veterans we serve include the hundreds of thousands at risk for limb loss and the tens of thousands who have experienced it, for whom the VA is committed to lifelong clinical management and care. We achieve our mission by conducting rigorous research and development, informing Veteran patients and providers, and translating knowledge and devices to the point of care.